Gastric Histopathology

GASTRIC HISTOPATHOLOGY CORE A SUMMARY
The primary mission of the Gastric Histopathology Core is to provide all Projects with high-quality
histopathologic characterization and quality assurance of tissues from rodent models of gastric inflammation and
neoplasia, immunohistochemistry (IHC) services with expert interpretation by experienced gastrointestinal
pathologists, access to human gastric tissues and tissue microarray services, quantitative analysis of histologic,
immunohistochemical and immunofluorescence staining of tissue sections and tissue microarrays, and large-
scale digital archiving through collaboration with Dr. M. Blanca Piazuelo and Dr. Kay Washington. The following
services are proposed:
1. To provide expert evaluation of histopathology of rodent models of H. pylori-induced gastric neoplasia and
correlation with human disease.
2. To provide priority access to custom high-quality, cost-effective research histology services, including
immunohistochemistry, multiplex immunostaining, and digital histomorphology.
3. To provide custom tissue microarray services and access to human gastric tissue samples with pathologic
annotation and clinical outcome.
The three component Projects and Core B (Proteomics and Metabolomics Core) of this Program Project
Grant all rely heavily upon morphologic analysis of gastric tissues isolated from rodent models of Helicobacter
pylori-induced gastritis and gastric neoplasia. Dr. Piazuelo’s and Dr. Washington’s high level of expertise in
interpretation of histopathologic changes in rodent models and in human tissues, as well as in interpretation of
immunohistochemical studies, will be critical to this work, and these collaborative activities are currently not
funded through existing resources. By utilizing the resources of a GI research-related immunohistochemistry
facility, it will be possible to achieve high standards for all histologic studies proposed in this grant. This
centralization of histologic services under the supervision of experienced pathologists with a dedicated interest
in gastrointestinal pathology will also allow careful attention to quality assurance. In addition, the access to
human gastric tissues allows each Project the ability to quickly translate findings in H. pylori-infected rodent
models of gastric inflammation and cancer to human disease along the cascade from non-atrophic gastritis to
intestinal metaplasia, and cancer. Core A will continue to collaborate with Core B by coordinating tissue
annotation for imaging mass spectrometry. Core A will also work synergistically with Core B by using IHC to
localize protein targets and validate expression changes identified by proteomics analysis and enzymes
implicated by metabolomics studies.

Public health relevance
CORE A NARRATIVE The work in this Core will help identify factors important in the development of gastric cancer. This may help identify persons at high risk for gastric cancer who can then be tested and treated for H. pylori. In addition, work performed in this Core may help find new treatment options to reduce the risk of developing gastric cancer.